Targeted small molecule recruitment to suppress the HIV transcriptionally active reservoir

PROJECT SUMMARY/ABSTRACT
Antiretroviral therapy (ART), introduced nearly 40 years ago, can durably suppress HIV replication but fails to
target the latent reservoir composed of resting CD4+ T cells and myeloid cells, such as microglia in the brain.
The intertwined nature of HIV and substance use disorder (SUD) exacerbates this issue, as addictive substances
increase the risk of HIV acquisition, persistence, and reactivation, especially in the brain, and a cure is still
missing for 1.4 million people worldwide who live with HIV and SUD. The long-term goal is to develop
therapeutically effective latency-promoting agents (LPAs) that “block” HIV reactivation in people with SUD and
“lock” HIV in a silenced state even after treatment interruptions. The overall objectives of this application are to
turn chemical inhibitors of the host CDK9, essential for transcription of the HIV genome, into LPAs and increase
their HIV specificity while reducing cytotoxic off-target effects by (i) using them in combination with protein
phosphatase 2A (PP2A) activators and (ii) developing targeted chemical recruitment strategies to specifically
deliver them to the HIV genome. These objectives will be accomplished through three specific aims: (1)
Determine the mechanism(s) by which CDK9 inhibition and PP2A activation block and lock HIV reactivation; (2)
Develop a targeted small molecule recruitment strategy for HIV silencing using a bifunctional system relying on
the specific interaction between FKBP12F36V and its ligand ortho-AP1867, and (3) Establish Tat/TAR binders for
the targeted small molecule recruitment strategy. In Aim 1, the efficacy and potency of existing CDK9 inhibitors
(AZD4573, SNS-032) and PP2A activators (SMAP-2), currently in clinical trials for cancer treatment, will be
evaluated for blocking and locking HIV reactivation in Jurkat cell lines, primary CD4+ T cells, and iPSC-derived
microglia, in the context of addictive substances. Underlying epigenetic and molecular mechanisms will be
studied in chromatin immunoprecipitation and RNA-seq experiments. In Aim 2, a targeted small molecule
recruitment strategy developed by the applicants, wherein the HIV transactivator Tat is genetically fused to
FKBP12F36V and the CDK9 inhibitor SNS-032 is chemically linked to an FKBP12F36V-directed ligand, ortho-
AP1867, will be developed and evaluated as an LPA to determine whether it can increase the local concentration
of the drug at the HIV promoter with minimal off-target effects in the presence of addictive substances. In Aim 3,
known chemical molecules naturally binding Tat or its RNA recruitment module TAR will be fused to CDK9
inhibitors and tested in different latency models to recruit CDK9 inhibitors to the HIV promoter without the need
for the FKBP12F36V tag, blocking transcription of untagged HIV. The central hypothesis is that when used in
combination and targeted specifically to HIV, CDK9 inhibitors act as LPAs that block HIV reactivation in the
presence of addictive substances without cytotoxicity, allowing durable “locking” even after treatment pauses.
The proposed research combines deep expertise in HIV biology and targeted kinase inhibition using modern
chemical genetics, paving the way for a functional cure for people living with HIV and SUD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it focuses on developing novel block-and-lock strategies for HIV cure, especially for people with substance use disorder, by suppressing the transcriptionally active reservoir of HIV using new methods to employ host CDK9 inhibitors in primary CD4+ T cells and microglia. Specifically, we are developing combination and targeted small molecule recruitment strategies for precise drug delivery to the HIV promoter using modern chemical genetics that increases the local concentration of the drug at the HIV genome while reducing cytotoxicity and off-target effects on other cellular genes, allowing for the use of lower concentrations of otherwise cytotoxic CDK9 inhibitors for clinical applications. These pharmacological approaches are particularly relevant to the NIH mission of achieving a functional HIV cure, potentially transforming the treatment landscape for people living with HIV and substance use disorder.